TRAINING GRANT IN VIRAL AND CHEMICAL CARCINOGENESIS

DESCRIPTION (provided by applicant): This is a renewal application for a postdoctoral training program in cancer biology based at the USC/Norris Comprehensive Cancer Center at the USC Keck School of Medicine. The principal goal of this program is to continue to provide Ph.D. and M.D. postdoctoral trainees with an interdisciplinary research experience of the highest quality. The program has four key elements. First and most importantly, trainees will conduct research under the supervision of a member of the Morris faculty;second, trainees will attend Grand Rounds, a seminar series that brings together clinicians and basic scientists on topics of mutual interest;third, trainees will present their work at one or more discipline-based research seminars, including eukaryotic gene regulation, epigenetics, and developmental biology;finally, trainees will have the option of attending didactic courses in a variety of subjects related to cancer biology, including courses in molecular genetics, human genetics, developmental biology, pathology, cancer biology, responsible conduct in research (required), and computational biology. These intensive graduate-level courses, which serve as a foundation of the highly successful, multi-departmental Program in Biological and Biomedical Sciences (PIBBS), will enable trainees to enhance their background in areas of cancer biology and medicine. The proposed program, in short, will provide trainees with both the practical experience and the scientific knowledge necessary for them to function as members of an interdisciplinary team whose goal is to translate basic discoveries into clinically useful approaches.